Data Science Core

RI-INBRE Data Science – Molecular Informatics Core (MIC) Project Summary
The overarching goal of the Rhode Island IDeA-Network of Biomedical Research Excellence (RI-INBRE)
program is to improve institutional capacity for biomedical research excellence and student experiential training
in the State of Rhode Island. The RI-INBRE Data Science – Molecular Informatics Core (MIC) provides
biomedical data science services to RI-INBRE and the broader research community. In this renewal application,
the MIC will restructure to reflect the expanded role of data science in biomedical research. The focus areas of
the MIC will extend well beyond bioinformatics and include biomedical data science, next-generation
sequencing, and 3D science visualization. Our model allows for future growth into new research areas, such as
cloud computing and machine learning/artificial intelligence, to meet the current and future research needs of
the RI biomedical community. We will provide bioinformatics and biomedical data science expertise, consulting,
analysis, and training to investigators in and out of the RI-INBRE network. Given the rapid pace of emerging
data science technologies, an essential goal of the MIC is to keep investigators and students informed of current
technologies and methodologies via multiple outreach and training efforts. The MIC will collaborate with the RI-
INBRE Centralized Research Core Facility to streamline and unify the omics data generation and analysis
pipelines to increase efficiency and improve user experience. The MIC will serve as a liaison between users
and other data science cores in the state and regional partners to ensure network investigators are apprised of
available services and have access to a comprehensive slate of data science tools. These MIC initiatives will
provide biomedical investigators with critical data science resources and training during the renewal period.
This will promote biomedical research career development and collaborations that will fuel economic growth in
the biotechnology, pharmaceutical, and life sciences industries in RI.